PS-OC Network Bioresource Core Facility (PBCF)

The goal of this project is to provide a central bioresource core facility, the PS-OC Network Bioresource Core Facility (PBCF), to all members of the Physical Sciences-Oncology Network. The PBCF shall serve as a biorepository and a distributor of standardized biospecimens and their molecular derivatives to the Physical Sciences-Oncology Network members.